The role of PPARγ in microglia pathobiologyafter exposure to repetitive mild traumatic brain injury

Exposure to repetitive mild traumatic brain injury (r-mTBI) can induce neurological damage many years
following the cessation of injury, contributing to an increased risk for neurodegenerative disease in later life. To
date, no suitable treatment strategies have been developed to rescue the persistent and long-term negative
consequences of r-mTBI. A greater emphasis should therefore be placed on understanding the underlying
pathobiological mechanisms driving the long-term neurological deficits after r-mTBI, as this could lead to the
identification of novel therapeutic targets. Neuroinflammation is a common feature of human and preclinical
animal models of TBI. The factors governing the propagation and persistence of neuroinflammatory responses
in the chronic sequelae of TBI remain elusive. We have established a mouse model of r-mTBI that recapitulates
many of the features of human TBI and thus represents a translationally relevant preclinical platform for such
studies. From this model we have generated a molecular library of microglia gene profiles at a range of
timepoints post-injury that provides a unique and detailed time-course of the microglial neuroinflammatory
response to r-mTBI. Particularly, we observed deficits in energy bioenergetics, altered glucose and lipid
metabolism, and a pro-inflammatory signature at chronic timepoints, which appeared to be driven by the loss
of constitutive PPAR𝛾𝛾 signaling in microglia. PPAR𝛾𝛾 is expressed in multiple cell types and plays a critical role
in regulating glucose and lipid metabolism, energy bioenergetics and inflammation. Treatment with a PPAR𝛾𝛾
agonist has shown efficacy in restoring behavioral and microglial pathobiological consequences in our r-
mTBI model. However, because multiple cell types express PPARγ receptors, pharmacological PPARγ ligands
lack the specificity needed to target microglial PPARγ signaling in vivo. In this new application, we plan to
clarify the constitutive role of PPARγ in regulating brain microglial cell responses in the context of TBI and
demonstrate whether microglia specific PPARγ activation mitigates TBI mediated neuroinflammation and
subsequent neurodegeneration in our r-mTBI model. We will compare TBI-dependent responses in the
presence or absence of PPARγ activation to reveal microglial specific targets that correlate with favorable
outcomes after r-mTBI and represent novel therapeutic targets. We will achieve this by utilizing a tamoxifen
inducible mouse model that specifically targets PPARγ activation in microglia. We will induce PPARγ activation
in microglia using a pre-injury tamoxifen treatment paradigm, and examine functional and pathobiological
outcomes, and glial cell transcriptomic profiles at 3 and 6 mo post-injury. Our goal is to clarify the role of
PPARγ as a master regulator of microglial pathobiology in the chronic sequelae of r-mTBI, and
to identify unique gene signatures and reparative mechanisms in microglia induced by PPAR𝛾𝛾 activation that
can be explored as novel microglial specific targets, not only in TBI but other neurodegenerative diseases where
neuroinflammation is a critical contributor.

Public health relevance
Exposure to repetitive mild traumatic brain injury (r-mTBI) can induce long-term neurological damage, and microglial mediated neuroinflammation is a common feature of TBI, which our data shows to be driven by the loss of constitutive PPAR? ? receptor activation in microglia. In this study, we will clarify the constitutive role of microglial specific PPARγ receptor as a novel target for ameliorating TBI mediated microglial pathobiology and subsequent neurodegeneration, utilizing a tamoxifen inducible mouse model that specifically targets PPARγ activation in microglial cells. From this study, we aim to identify unique microglial specific gene signatures and reparative mechanisms induced by PPAR? ? activation that can be explored as novel microglial specific therapeutic targets in future work to promote neurological health in TBI and related neurodegenerative diseases where neuroinflammation is a common denominator.